University of Pittsburgh Clinical and Translational Science Institute

Since 2006, the Clinical and Translational Science Institute (CTSI) has fundamentally transformed the
University of Pittsburgh (Pitt) and its approach to training scientists (2,419), its conduct of research (6,551
studies), and its community engagement (>200 community partners) and the integration of research in health
practice across western Pennsylvania (>250K research participants in Pitt+Me Registry). We established
clinical and translational science as a new academic discipline across Pitt and its affiliated healthcare system,
UPMC, and created the infrastructure and workforce needed to sustain it. We are now poised to pivot from
successfully enabling the sequential translation of individual studies to systematically accelerating the real-
world impact of research. We define “research impact” as changing standards of care through the
dissemination and sustained implementation of best practices supported by translational research evidence.
Over the next 5 years, we will provide the training, resources, and expertise necessary for CTSI-supported
studies to develop a “path to impact” and thus support progress toward achieving our mission: CTSI will
accelerate the dissemination and implementation, and hence the impact, of translational research. Each CTSI
program has new activities specifically designed to support specific steps on the path from idea to impact:
Team Assembly, Study Design, Study Conduct, Dissemination & Implementation. We will create translational
research teams who envision the impact of their work on the communities that they seek to benefit (patients,
providers, policymakers, etc.) at each step of the research process, from conceptualizing questions through
implementing findings. Every CTSI-supported study will be “designed for impact”.

Public health relevance
Over the next 5 years, we will create translational research teams who envision the impact of their work on the communities that they seek to benefit (patients, providers, policymakers, etc.) at each step of the research process, from conceptualizing questions through implementing findings. Every CTSI-supported study will be “designed for impact” (i.e., articulate paths for dissemination to and implementation by stakeholders).